NONTUBERCULOUS MYCOBACTERIA IN PATIENTS WITH CYSTIC FIBROSIS

To determine the prevalence of nontuberculous mycobacterium colonization in patients with CF and to further determine the impact of NTM on the natural course of CF and lung disease.